Free Text Gene Name Recognition

We have begun the development of a system to recognize gene or protein names in natural language text. The system currently consists of two modules. One is a Bayes text classifier that we have trained on over 500k documents that contain known gene names. These documents are compared with the remainder of the text in PubMed and the difference is learned using the naive Bayes classifier. The second module is the Brill tagger that we have modified to run on text with a biological orientation. We have taken an additional step to teach the tagger to tag gene names consisting of a single word with a GENE tag. Several hundred additional rules have been learned in this regard. Several processing steps are applied as filters after the tagger to identify gene names which are multi-term, etc. We are currently evaluating the performance of this system in recognizing gene names in a test set of text. The plan is to continue work on this system and to incorporate new approaches into the basic system to improve it further.